Hereditary Genetics of Hepatocellular Carcinoma

Abstract
This
CA-22-057. The parent grant (1R01CA259201), Hereditary
application is being submitted in response to the Notice of Special Interest
Genetics of Hepatocellular Carcinoma
(NOSI) identified as NOT-
, was
established through funding from the National Cancer Institute (NCI) (PI, Dr. Kirk J. Wangensteen). The aims of
the parent grant are to discover rare inherited pathogenic or likely pathogenic (P/LP) genetic variants associated
with hepatocellular carcinoma (HCC) development (Aim 1), and to investigate whether carriage of inherited
defects in homologous recombination DNA damage repair (HR-DDR) genes render HCC tumors sensitive to
PARP inhibitor therapy (Aim 2). The scientific focus of this Supplement aligns with Aim 1 of the parent
grant and is focused on multiethnic investigations into heritable genetic predisposition to HCC. Specifically, this
Supplement adds value to the parent grant by expanding the population under study in Aim 1 to include global
ethnic minority populations in sub-Saharan Africa and South America with the same focus on hereditary factors
associated with HCC development in these underserved populations.
Globally, HCC is the 3rd leading cause of cancer-related deaths, and its incidence is rapidly increasing in
many regions of the world. There are marked geographic differences in the incidence of HCC and countries in
Sub-Saharan Africa, such as Ghana, have some of the highest HCC incidence rates worldwide. Parts of South
America also have high incidence of HCC, and HCC is often diagnosed at early ages in the region. Importantly,
unlike Asia, Europe, and the US where several studies on the hereditary genetics of HCC have already been
conducted, studies are lacking in sub-Saharan Africa and are under-investigated in Hispanics in South America.
This supplement focuses on investigating the prevalence of rare germline P/LP variants associated with
susceptibility to HCC among sub-Saharan African HCC patients from Ghana and Hispanic HCC patients from
six South American countries (Argentina, Brazil, Chile, Colombia, Ecuador, and Peru) for comparison to each
other and to populations from the United States from the parent grant (Aim 1). The Supplement further
investigates differences in P/LP variant enrichment by first-degree family history of liver cancer and age at HCC
diagnosis (Subaim 1a). It also examines the impact of genetic admixture for insights into the relative ancestral
genetic contributions to HCC susceptibility among native Africans from Ghana and Hispanics from South
America and compares with each other, and to African Americans and Hispanics in the US from the parent grant
(Subaim 1b). Within the scope of this application, we will complete whole-exome sequencing and analysis of
germline DNA among native Africans from Ghana (n=150) and Hispanics from South America (n=150) – two
ethnic groups that are not represented in the parent grant or in any previous study. The cohesive team of experts
assembled for this project will add value to the parent grant by including high-risk global minority populations in
our effort to identify genetic risk variants associated with HCC development, in a timeline of less than one year.

Public health relevance
Project Narrative Investigations of the genetic etiology of hepatocellular carcinoma (HCC), a leading cause of cancer-related deaths worldwide, is lacking in sub-Saharan African populations and is understudied in other minority groups, such as African Americans and Hispanics. A potentially significant role of inherited genetic predisposition to HCC in minorities is underscored by a much earlier age of HCC diagnosis and a strong association between a positive family history of HCC and higher risk for developing HCC. This multiethnic study is designed to discover unique heritable genetic variants associated with HCC development in sub-Saharan Africans from Ghana and Hispanics in six South American countries for comparison to each other and to US populations from the parent grant to improve risk stratification, enhance early detection and identify potential therapeutic targets.